CORE--Immunology applications

DESCRIPTION (provided by applicant): The Immunology Applications Core Facility (IACF) was created in 1998 by combining three of the existing UCCRC core facilities - the Flow Cytometry, Immunohistochemistry and Fitch Monoclonal Antibody facilities. These facilities serve the faculty by providing access to state-of-the-art immunological technologies and quantitative analytical approaches to measure molecular, cellular and tissue function. These facilities, which are utilized by Cancer Center researchers in many areas of study, serve basic research in cellular structure/function as well as translational research in clinical applications and molecular medicine. The Flow Cytometry Facility provides analytical detection and sorting of single cell suspensions and sub cellular components using multiparameter fluorescence technology. Services include training on use of benchtop flow cytometers, cell sorting using high speed, conventional speed and magnetic bead technologies. The Immunohistochemisty Facility provides cellular detection within the context of the surrounding tissue. The services include tissue sectioning, H&E staining, Immunostaining and in situ hybridization using both manual and automated staining technologies. The Fitch Monoclonal Antibody Facility provides the antibodies necessary for the detection of cells and subcellular components. The services provided include novel antibody production (immunizations and splenic fusion to myeloma cells), large scale antibody production using hollow fiber bioreactor systems and antibody purification. The facilities expanded into newly renovated space in February, 2001. This allows the facilities to continue to grow to meet the research demands of the UCCRC faculty.